AI-enhanced metabolic imaging: a non-invasive and precise IVF assessment tool

Project Summary
The development of a non-invasive, objective embryo viability assessment remains an unmet
need in IVF treatment. In this work, Optiva Fertility aims to develop a novel embryo assessment
based on metabolic imaging using Fluorescence Lifetime Imaging (FLIM) in conjunction with
artificial intelligence (AI) techniques. To date, Optiva Fertility has designed, tested, and deployed
a first generation metabolic imaging system and has commenced clinical work.
Bringing this technology to the point where it provides significant benefit to IVF patients requires
a multi-stage development and verification process which forms the basis for the proposed work
in this grant. Based on the results from an observational pilot trial, Optiva will design a large
scale, multi-site observational trial. The purpose of this study is to obtain a dataset large enough
to train robust AI models for assessing embryo viability. Facilitating this trial will require
engineering and constructing a second generation metabolic imaging system featuring a more
compact and integrated hardware design, automated calibration, upgraded controls software,
and enhanced imaging technology. It is anticipated that this system will be very similar to the
eventual commercial product. Successful completion of this work will further the understanding
of the role metabolism plays in embryo viability, as well as leave Optiva well positioned to
undertake a pivotal interventional trial.

Public health relevance
Project Narrative Optiva Fertility is developing novel embryo/egg assessment technologies by combining metabolic imaging and other advanced microscopy methods with artificial intelligence techniques. This work will provide a deeper understanding of the role metabolism plays in human embryo viability, and will produce a non-invasive and objective embryo assessment service with the potential to significantly increase the odds of pregnancy for those undergoing IVF treatment.